DEVELOPMENT OF COMPETING RISKS SURVIVAL PARAMETRIC MODELS FOR CONTINUOUS TIME IN TWO-TIME SCALES.

PURCHASE ORDER: DEVELOPMENT OF COMPETING RISKS SURVIVAL PARAMETRIC MODELS FOR CONTINUOUS TIME IN TWO-TIME SCALES. In support of THE SURVEILLANCE RESEARCH PROGRAM.